Administrative Core

The Administrative Core of the Center of Excellence (CoE) serves as an organizational hub, providing leadership
and coordinating the activities of the Community Development and Education Core (CDEC), Model and Data
Sharing Core (MDSC), three Research Projects (RP), and the broader Infectious and Immune-mediated Disease
(IID) modeling community. The Administrative Core is led by a computational immunologist and an experimental
immunologist with leadership experience and complementary scientific expertise. They are assisted by staff with
significant experience in grants administration, financial management, team science, and project management.
The Core is responsible for ensuring that the CoE fulfills its goals of driving research innovation in bridging
models at different scales and coordinating multiscale modeling research across the IID community. To achieve
this, the Core will provide organizational, administrative, and scientific leadership, provide fiscal
management and stewardship, promote integration within the Center and across the IID community,
administer the Opportunity Fund, and develop strategic and tactical plans to pivot to a disease outbreak.
Functionally, the Core provides oversight of administrative procedures, regulatory compliance, communications,
and scientific activities, provides project management services to the MDSC, CDEC, and RP, manages the CoE
budget and finances, including tracking expenditures and balances for each core and RP, and coordinates with
the Internal Advisory Committee (IAC), External Advisory Committee (EAC) and NIAID to ensure effective
governance of CoE resources. The Core will coordinate with the NIAID Project Scientist to accomplish CoE
program goals, discussing projects to be funded through the Opportunity Funds, and scheduling bimonthly
teleconferences with the CoE leadership team. The Core facilitates integration within the CoE and across the IID
community by ensuring that resources and infrastructure developed by the MDSC and CDEC are widely
disseminated and optimally utilized. Within the CoE, the Core convenes regular meetings with the CDCEC,
MDSC, and RP leaders, conducts team science training sessions, and organizes the annual offsite retreat. For
the broader IID modeling community, the Core disburses the Opportunity Funds to encourage innovation in
multiscale modeling, works with the MDSC to develop informatics infrastructure to advance FAIR principles for
multiscale data and models as well as leverage generative AI to democratize access to immunology databases,
and coordinates with the CDEC to provide monthly multiscale modeling webinars, offer mentored scholars
programs, provide navigation services to link computational and experimental collaborators, develop the IID
model network (IIDMN) online community, and organize the annual conference. Overall, the Administrative
Core will provide the leadership, support, and coordination necessary to create multiscale modeling
communities, democratize access to data, improve model reusability, develop innovative bridging
frameworks, and train the next generation of researchers.